Mobile element mutagenesis as a driver of human cancers

Project Summary.
Human LINE-1 (L1) elements are autonomous retrotransposons that continue to produce new
“offspring” L1 insertions in human genomes. Until recently, L1 elements were thought to be mobilized primarily
in the germline and then silenced in somatic cells throughout adulthood. However, several recent reports have
shown that L1 elements are active in at least some adult somatic tissues, including the brain and epithelial
somatic tumors. These observations have led to the suggestion that L1 might play a role in initiating human
cancers by mutating specific tumor suppressor genes and oncogenes in somatic cells. In the three aims of this
proposal, we will further explore this hypothesis with an emphasis on studying the expression, regulation, and
mobilization of the full-length L1 source elements that generate new L1 insertions. In Specific Aim 1, we will
generate a comprehensive resource of full-length, human-specific L1 (FL-L1Hs) source elements that will be
used throughout this proposal (Aims 1-3) to study the role of L1 mobilization in human tissues and tumors. In
Specific Aim 2, we will examine the expression and regulation of FL-L1Hs elements that can evade somatic
repression and will study the mechanism(s) whereby these elements manage to do this. Finally, in Specific
Aim 3, we will examine the mobilization capacities of FL-L1Hs elements. Combined with the data generated in
Aims 1 and 2, these data will allow us to better understand the expression, regulation, and mobilization of the
FL-L1Hs elements that mutagenize the human genome. The successful completion of the three Aims of this
study will transform our understanding of how mobile elements impact human diseases, including cancers.

Public health relevance
Project Narrative. The central goal of our project is to better understand the role of mobile genetic elements in human cancers. Because new mobile element insertions (MEIs) can initiate human cancers, our work is relevant to the mission of the National Cancer Institute.